NOISE EFFECTS ON COCHLEAR TRANSCRIPTION FACTORS

The conversion of sound into a neural signal is a result of neurotransmitter release from mechanically stimulated auditory hair cells and is regulated in part by efferent neuronal feedback. Suprathreshold mechanical or neurochemical stimuli are thought to initiate adaptive processes in the cochlea and may activate intracellular regulatory mechanisms that result in changes in the pattern and rate of gene expression. Such changes in gene expression allow a cell to respond to prolonged or potentially damaging stimuli in s specific and organized manner. The transcription factors designated CREB and CREM are one of the primary means by which extracellular stimuli control the rate of gene expression. Increases in cyclic AMP, calcium or other intracellular messengers result in the activation of CREB and CREM, which in turn bind to specific DNA sequence elements on target genes. This initial sequence of events is the driving force for the regulated expression of numerous genes. The proposed research will examine activation and expression patterns of CREB and CREM in the gerbil cochlea in order to characterize pathways for genetic control mechanisms and to test the hypothesis that sound at damaging intensities triggers CREB and CREM-mediated gene regulation the initial Specific Aim is the analysis of activated CREB in the noise-exposed cochlea by immunochemical techniques. In situ hybridization will then be used to achieve the second Specific Aim: the cellular localization of induced expression of the ICER isoform of CREM, gene known to be regulated by CREB. These studies will provide information needed to provide rationale for the prevention and treatment of noise-induced hearing loss.